Discovery of Thymidylate Kinase Inhibitors for Anti-Fungal Applications

Discovery of Thymidylate Kinase Inhibitors for Anti-Fungal Applications
Abstract:
Infections due to the fungal pathogen Candida albicans are devastating to the human population. C.
albicans causes over 40,000 cases of invasive candidiasis/year in the US alone, with an estimated mortality
rate of approximately 20%. There are only a small number of approved anti-fungal agents and resistance to
these drugs is becoming common. We propose to isolate and characterize inhibitors of thymidylate kinase
that can be developed as anti-fungal drugs. Thymidylate kinase catalyzes the phosphorylation of thymidine
monophosphate to diphosphate, and it is an essential step in the production of TTP, which is required for
DNA replication and repair. We propose to use high-throughput screening (HTS) of compound libraries,
computational drug discovery, and Nuclear magnetic resonance (NMR) based screening of fragment
libraries, to identify lead compounds. The proposal leverages expertise in thymidylate kinase enzymology
and NMR (Rule), HTS (Johnston), computational chemistry (Isayev), and C. albicans biology (Mitchell).

Public health relevance
This research project will identify compounds which inhibit a key enzyme in the DNA metabolism of the pathogenic fungus, Candida albicans, that is responsible for many clinical infections, especially on medical implants. The enzyme is thymidylate kinase and it is required for the synthesis of TTP, one of the four nucleotides required for DNA replication and repair.